SPECIAL MUTAGENICITY STUDIES WITH SALMONELLA

To test samples, provided by the NTP, for mutagenicity in Salmonella. The test protocols used will often be designed for the particular test sample, rather than a standard protocol as is used by other contractors. Approaches to testing different substances will be designed by the contractor following consultation with the project officer.